A General Synthetic Route to Glycosidase Inhibitors

DESCRIPTION (provided by applicant): The goal of the research outlined in this proposal is to investigate the scope of the palladium catalyzed dynamic kinetic asymmetric transformation (DYKAT) of racemic diene monoepoxides to enantiomerically pure 1,2-aminoalcohols and to apply this methodology to the synthesis of the natural products 2,5-dihydroxymethyl-3,4-dihydroxy- pyrrolidine, 1-deoxynojiromycin, swainsonine, 1-epi-alexine, and gualamycin, which are potent glycosidase inhibitors and represent four of the five general structural classes of these compounds. The reaction will be investigated by expanding the list of nitrogen nucleophiles and epoxides that can be used. In optimizing the reactions, advanced intermediates necessary for straightforward transformation into these inhibitors will be generated. Efficient enantioselective chemical syntheses by flexible routes using the proposed DYKAT methodology will provide a general synthetic strategy for the synthesis of a multitude of structurally similar alkaloids, which have been identified as potential pharmaceuticals in the therapeutic areas of cancer, diabetes, obesity, and anti-virals.